Training in Neurodegenerative Diseases

PROJECT SUMMARY
Neurodegeneration Training Program (NTP) is an inter-departmental training program in the School of
Medicine (SOM) at Case Western Reserve University (CWRU) aiming to provide trainees with the fundamental
skills necessary for outstanding careers in neurodegeneration research, together with an appreciation of the
challenges and complexity of diagnosing and treating neurodegenerative diseases in the clinical setting. The
NTP emphasizes rigorous PHD training in fundamental aspects of neurodegeneration and mechanisms of
diseases involving neurodegeneration and clinical perspectives through classroom teaching,
neurodegeneration-related laboratory research and mentored neurodegenerative clinical experiences
combined with educational forums that address quantitative approaches and important topics in clinical and
translational neurodegeneration research. The NTP has been designed for students in year 3 and beyond to
provide differentiated rigorous pre-doctoral scientific training in the field of neurodegeneration along with
extensive clinical exposure. NTP will draw pre-doctoral trainees from four component PHD training program
(Neuroscience, Pathology, Genetics and Physiology & Biophysics) as the departments of Neuroscience,
Pathology, Genetics and Physiology & Biophysics house the majority of faculty involved in neurodegeneration
research and individual training program in each of these departments provide rigorous basic training in its
discipline which form the solid basis and better prepare the trainees for more specialized training in
neurodegeneration as afforded by this NTP. A competitive pool of trainees will combine with 27 outstanding
faculty in state-of –the-art facilities to investigate a wide range of neurodegeneration-related topics. The NTP
promotes collaboration between departments and schools at Case Western Reserve University, particularly the
School of Medicine, and with its affiliated institutions in the Cleveland area: University Hospitals Cleveland
Medical Center (UHCMC), and the Cleveland Clinic Foundation (CCF, including the Lerner Research Institute).
All of these institutions are within walking distance of each other and this rich training environment enjoys very
active basic science and clinical activities. The updated curriculum provides a solid foundation for
neurodegeneration research with an emphasis on experimental design, statistical methodologies and
quantitative approaches. The well-received mentored neurodegenerative clinical experience has been
expanded to include seven renowned clinicians enabling direct interaction with patients and caregivers in
several different clinical centers close to CWRU campus providing motivation to the trainees to produce
advances in disease diagnosis and therapies. The career development and professional enrichment module
ensures better preparedness of our trainees to achieve their desired career goals. Together, NTP training will
provide trainees a solid foundation for an outstanding neurodegeneration-related career.

Public health relevance
PROJECT NARRATIVE The Neurodegeneration Training Program provides training to outstanding predoctoral students to become leaders of academic, clinical, or pharmaceutical research programs focused on neurodegeneration. The program emphasizes rigorous and quantitative neurodegeneration research, mentored clinical experience with patients, and career development skills necessary for making successful translational advances for maintaining a healthy aging population.